Role of Altered Mitochondrial dynamics in Graft Versus Host Disease

Project Summary
: Graft-versus-host disease (GVHD) is the leading cause of non-relapse mortality following
hematopoietic stem cell transplantation (HSCT). The severity of GVHD has been linked to the release of damage
associated molecular patterns (DAMPs) in response to cytotoxic pre-HSCT conditioning mediated tissue injury.
Recently, we have shown that the conditioning mediated release of damaged mitochondria (exMito) directly
contributes to the initiation of GVHD. In this proposal, we will identify the mechanistic pathways leading to
generation and release of dysfunctional mitochondria during pre-HSCT conditioning in order to discover new
therapeutic targets to prevent GVHD.
We have found that cytotoxic pre-HSCT conditioning leads to excessive mitochondrial fission
independent of mitochondrial autophagy (mitophagy), creating an imbalance in mitochondrial dynamics which
results in extracellular release of dysfunctional mitochondria. Using mouse models, we found that exposure of
host immune cells to these released mitochondria during HSCT accelerated the onset and severity of acute
GVHD. Importantly, our preliminary data demonstrates that correcting mitochondrial dynamics by decreasing
mitochondrial fission and inducing mitophagy prevents extracellular release of damaged mitochondria following
conditioning.
Our overall hypothesis is that correcting impairments in mitochondrial dynamics will decrease exMito
release following conditioning and prevent GVHD without impairing donor HSC function. To test this hypothesis,
we will first determine the downstream mechanisms which link excessive mitochondrial fission to exMito release,
host APC activation, and incidence of GVHD. Second, we will determine how impairments in mitophagy impact
conditioning-mediated exMito release and incidence of GVHD. Finally, we will determine the impact of targeting
mitochondrial dynamics on donor HSC function following transplant.
This project addresses a major clinical barrier for HSCT by identifying targetable mechanisms that
mediate the initiation of GVHD and testing novel biologically driven therapeutic candidates. Specifically, we will:
1) define novel mechanisms that mediate impairments in mitochondrial dynamics and extracellular mitochondrial
content secondary to conditioning, 2) apply single cell approaches to characterize how impairments in
mitochondrial dynamics impact the immune cell response following conditioning for HSCT, and 3) determine the
impact of altered mitochondrial dynamics on HSC function following transplant. Altogether, this will provide the
foundation for a new class of therapeutics beneficial for prevention of GVHD and other inflammatory disorders.

Public health relevance
Project Narrative Our group has demonstrated that pre-HSCT conditioning mediates impairments in mitochondrial dynamics, resulting in tissue damage and extracellular release of dysfunctional mitochondria which exacerbate GVHD. However, therapies which prevent pre-HSCT conditioning mediated mitochondrial damage are currently unavailable. This proposal, which investigates the mechanisms responsible for generation and extracellular release of dysfunctional mitochondria following pre-HSCT conditioning, will provide a novel non- immunosuppressive class of therapeutics for prevention of GVHD.